Response of tsetse flies to trypanosome-induced odors

Project Summary
The tsetse fly transmits trypanosomiasis to humans and animals across 38 countries of Africa. In
humans the disease is called African Sleeping Sickness. There is no vaccine to prevent it, and 70 million
people are at risk. In animals the disease is called nagana, and it imposes a major economic burden on sub-
Saharan Africa. The most effective means of preventing these diseases has been to control the tsetse flies that
spread them, and olfactory traps have been particularly useful. Tsetse flies find their human and animal hosts
largely through olfactory cues. The flies also depend on olfaction to avoid predators, find mates, and identify
sites on which to deposit their offspring. Better understanding of the tsetse olfactory system may lead to better
means of control.
Parasites use a rich variety of strategies to increase their reproductive success through manipulation of
their vectors and hosts. We have recently discovered that infection with trypanosomes leads to the production
of 21 volatile compounds in tsetse. This proposal tests hypotheses about the neuronal, receptor, and
behavioral responses of tsetse flies to these volatile compounds. The first aim investigates the
electrophysiological response of tsetse antennal neurons to trypanosome-induced odorants. This analysis will
determine which individual chemical compounds are most effective at low concentrations. These compounds
may be useful in controlling tsetse and other insect vectors of mammalian diseases. The second aim measures
the response of tsetse odorant receptors to trypanosome-induced odors, taking advantage of an in vivo
expression system in Drosophila. The third aim tests hypotheses about behavioral responses to trypanosome-
induced odors using a two-port olfactometer. It will also test the impact of trypanosome-induced odors on
mating behavior.
The proposal should provide new insights into one of the most important themes in vector biology: the
biological interactions between the parasites that cause disease and their vectors. The experimental plan is
designed to test hypotheses about the trypanosome-induced odors and the responses of tsetse flies to them.
The study may also identify odorants that are useful in controlling tsetse in the field and thereby reducing the
incidence of the diseases that they spread.
The proposal will provide training in electrophysiology and molecular biology to Dr. Shimaa Ebrahim,
who has little experience in these topics. The project will benefit from an environment that contains a great deal
of expertise in insect olfaction. The study takes unique advantage of resources at Yale, which is one of the
world's centers of tsetse research.

Public health relevance
Project Narrative Tsetse flies spread trypanosomiasis to humans and animals. Flies infected with trypanosomes produce different volatile compounds than uninfected flies. This project is designed to elucidate at the neuronal, receptor, and behavioral levels how tsetse flies respond to trypanosome-induced odors. The results may lead to novel ways of controlling tsetse flies and the diseases they spread.